PERFORMANCE OF PREGESTATIONAL AND GESTATIONAL DIABETES

This study examines the relationship between diabetes in pregnancy and maternal and fetal complications. Metabolic control is monitored by memory meter and Hb A1c determinations.